Social Medical and Economic Demography of Aging

DESCRIPTION (provided by applicant): The purpose of this predoctoral and postdoctoral research training program is to provide rigorous training in the general fields of social, medical, and economic demography of aging. A major focus is placed on five substantive areas: a) biodemography, including indices and models of aging, vitality, and frailty, b) health disparities (by race/ethnicity, sex, socioeconomic status) among the elderly;c) international comparative studies of the health of aging populations in both developed and developing countries;d) important life course transitions (e.g., family changes, work and retirement, morbidity and disability) that relate to the health and well-being of aging persons;and e) the economics of aging. These areas require a core of researchers with doctoral and postdoctoral training who are skilled in state-of-the-art analytic methods and population modeling. The training program is administered jointly through the Duke Population Research Institute (DuPRI), an interdisciplinary research organization of Duke University and the Department of Sociology. DuPRI represents a reorganization and relocation of the Duke Center for Demographic Studies, which was historically associated with this training grant since its inception. Predoctoral training is carried on with the full collaboration of the graduate training programs of the Departments of Sociology, Economics, and Public Policy in which doctorates are awarded. The training takes place at DuPRI, the Departments, and the Center for the Study of Aging and Human Development. The facilities at all these sites are utilized by both predoctoral and postdoctoral trainees. Eight predoctoral trainees with various background levels will be appointed in each year to conduct aging studies through the completion of their doctoral dissertations, normally four to five years for entering students with B.A. degrees. Trainees must fulfill all theory and methods requirements of a Ph.D. in sociology, economics, or public policy. In addition, all trainees must take required courses in the demography of aging and in demographic models and methods. At the postdoctoral level, three appointments of persons with a Ph.D. or equivalent degree will be made. These postdoctoral trainees typically will be recruited with varied levels of experience for two-year periods of training. They gain first-hand experience under direct supervision of preceptors on major ongoing research projects. They also are provided the opportunity of taking appropriate courses to obtain advanced training knowledge in needed methodological and substantive areas. RELEVANCE: Population aging is a general problem faced both domestically in the U.S. and internationally in the 21st century. Associated questions regarding health and longevity will become more and more salient. The purpose of this predoctoral and postdoctoral research training program is to train researchers who are skilled in state-of-the-art analytic methods and population modeling and who can analyze and project population trends in aging and health.